Administration

Project Summary
Administration
We have refined our administrative infrastructure to efficiently manage the integrated efforts of advancing OCT
technology, providing services to a broad community of collaborators, and pursuing an effective agenda of
training and dissemination. Our administrative aims remain to:
1. Establish and administer procedures to ensure the fluid integration of operations in TRDs, CPs, and
SPs.
2. Facilitate training and dissemination broadly, across a varied spectrum of technical, pre-clinical, and
clinical communities.
3. Ensure the responsible conduct of research and reporting under NIH and MGH institutional guidelines.
CBORT resides within the Wellman Center for Photomedicine, one of five thematic centers of the
Massachusetts General Hospital. Within CBORT, the administrative structure includes the Director (Brett E.
Bouma), Associate Director (Benjamin Vakoc), the Resource Management Committee (Professor Yun, the TRD
leaders and Dr. Namati). Scientific review of the research conducted within CBORT is facilitated by an annual
meeting with an external advisory board.